TRD 2: Metabolic Markers

TRD 2: Metabolic Markers
Lead Principal investigator: Richard Edden, Professor of Radiology
Co-investigators: Peter van Zijl, Peter Barker, Georg Oeltzschner, Jiadi Xu, Hye-Young Heo,
Nirbhay Yadav.
This TRD will develop biomarkers of brain metabolism, using magnetic resonance spectroscopy
(MRS) and chemical exchange-saturation transfer imaging (CEST-MRI). We will develop new
editing schedules for multiplexed editing MRS, allowing the simultaneous resolution of several
low-concentration metabolites of interest to collaborative projects, including neurotransmitters
such as GABA, antioxidants such as glutathione, and neuromodulators such as N-
acetylaspartylglutamate. We will combine these methods with spectroscopic imaging readouts
and develop multi-spectrum linear combination modeling approached for quantification. Edited
CEST approaches, tuning acquisition parameters to improve specificity of detection, CEST
fingerprinting, and single-shot z-spectrum approaches will be developed. Deep learning tools
for the analysis of these data will also be developed, with a particular focus on the integration
of methods, and spectral resolution enhancement and metabolic editing by MRSI-based
training of CEST analyses. Acquisition and analysis tools developed under this TRD will be
disseminated to collaborative projects and service projects, to establish reproducibility in a new
setting, and to the broader community.

Public health relevance
This TRD will develop new methods to measure biomarkers of brain chemistry using an MRI scanner, both by directly detecting signals from small molecules in the brain (with edited magnetic resonance spectroscopy MRS) and indirectly (using the contact between protons in the metabolites and water) with amplification by detection through the water signal). These two methods will also be integrated using machine learning to benefit from their complementary strengths of detection specificity and detection sensitivity, respectively.